Investigation of the cell of origin and evolutionary trajectories of human glioblastoma

Abstract
Tumor cell of origin is a major determinant of cancer evolution. While the cell of origin of several tumor
types has been successfully identified, glioblastoma, a malignant primary brain tumor, remains deprived of such
biological information. Although rigorous studies have identified potential candidates among central nervous
system cytotypes, a clear consensus of the early tumorigenic steps in glioblastoma has yet to be achieved.
Unveiling glioblastoma cell of origin will shed a light on its evolutionary trajectories and, ultimately, better explain
disease heterogeneity and poor clinical outcomes.
To investigate cell of origin of glioblastoma, I generated multiple technological tools leveraging i)
CRISPR/Cas9 genetic engineering, ii) human induced pluripotent stem cells derived cerebral organoids, iii)
adeno-associated- and lentiviral gene delivery, iv) genome-tagging dynamic-barcoding. This work laid the
foundation of the generation of human pre-clinical model of spontaneous gliomagenesis, thus allowing to trace
and characterize early steps of human gliomagenesis.
The overarching hypothesis of this research plan is that cell-specific molecular programs are permissive
to malignant transformation under the selective pressure of known genetic drivers. To test this hypothesis, the
Aim 1 of this work will be focused on characterizing histopathological and transcriptomic alterations following key
driver events to provide detailed annotations of early glioblastoma tumorigenesis. To complement Aim 1 and
improve our understanding of glioblastoma tumorigenesis, Aim 2 will be focused on developing a reliable platform
that will permit to lineage trace glioblastoma cell of origin thanks to a sophisticated CRISPR/Cas9 barcoding
technology. Single cell RNA sequencing of these models will generate a computational framework able to identify
normal cells susceptible to gliomagenesis and transcriptional programs that lead malignant transformation.
Comparative analysis with publicly available single cell RNA sequencing dataset of patient derived glioblastoma,
will further advance our knowledge regarding tumor progression.
This study will define a comprehensive panoramic of glioblastoma tumorigenesis and clarify its cell of
origin, opening new avenues for future clinical therapeutic strategies.

Public health relevance
Project narrative Glioblastoma is the most common primary brain tumor in adults characterized by dismal prognosis and few therapeutic options. Reconstruction of molecular events driving glioblastoma heterogeneity from the early steps of tumorigenesis to advanced disease is essential to develop future meaningful clinical approaches. This proposal aims to generate pre-clinical models of glioblastoma to interrogate its evolutionary trajectories and putative cell(s) of origin in order to depict a comprehensive overview of disease progression, thus improving patients’ management.